Improving Access to Hydroxyurea for Adults with Sickle Cell Disease

DESCRIPTION (provided by applicant): Our overall goal is to improve utilization of hydroxyurea for adults with sickle cell disease. Hydroxyurea (HU) therapy is currently the only disease-modifying pharmaceutical agent available to treat adult patients with sickle cell anemia (SCA). A recent NIH consensus panel reviewed the available evidence regarding HU treatment for SCD and found it to be safe, efficacious, and effective (Brawley et al., 2008). This review also found HU to be highly underutilized. We have previously identified provider barriers to the use of HU which included many concerns about patient compliance and concerns over toxicity. As SCD is a rare disorder, a large multistate study will be needed to test interventions to improve utilization of HU in this patient population. The design of this large trial will entail having hem/onc providers participate in a web based intervention to improve knowledge and decrease barriers to prescribing HU and then randomize their patients to an intervention to improve adherence. The primary aim of this large multicenter trial will be to demonstrate that the intervention decreases hospital and emergency room visits for adults with SCD eligible for HU. The purpose of this R34 grant is to gather data needed in order to do the larger study. With this grant we well characterize the patients seen by community hematologist/oncologists (Aim1), refine and test (Aim 2) a behavioral intervention designed to reduce the informational and attitudinal factors which contribute to hematologists/oncologists reluctance to prescribe HU to SCD patients and finally assess the feasibility (Aim 3) of training clinic staff to provide problem solving to patients to improve adherence to HU. Based on data from our previous studies on provider identified barriers to HU our central hypothesis is that lack of knowledge by hematologists/oncologists regarding the management of HU, as well a lack of appropriate tools to overcome barriers to its use, significantly contribute to the underutilization of HU.

Public health relevance
PUBLIC HEALTH RELEVANCE: Improving access to hydroxyurea for adults with sickle cell disease will improve the quality of lif and health for those with the disease. In addition, improved utilization of hydroxyurea will lead t fewer emergency room visits and hospitalizations and decrease the financial burden caused by this disease. (End Abstract) __SpecificAimsTextDelimiter__ Specific Aims Our overall goal is to improve utilization of hydroxyurea for adults with sickle cell disease (SCD). Hydroxyurea (HU) therapy is currently the only disease-modifying pharmaceutical agent available to treat adult patients with sickle cell anemia (SCA). A recent NIH consensus panel reviewed the available evidence regarding HU treatment for SCA and found it to be safe, efficacious, and effective4. This review also found HU to be highly underutilized. Consequently, the expected benefits of HU have not been realized and therefore, it is imperative that we improve access to HU for people with SCD. We have previously identified provider barriers to the use of HU which included many concerns about patient adherence and HU toxicity. As SCD is a rare disorder, a large multistate study is the only way to test interventions to improve utilization of HU. The design of the larger trial will entail having hematology/oncology (hem/onc) providers participate in a web based intervention to improve knowledge and decrease barriers to prescribing HU as well as randomizing patients in their clinics to receive either an empirically validated intervention to address patient non-adherence or usual care provided by the hem/onc provider. The primary outcome of this large trial will be a decrease in hospital inpatient and emergency department utilization by those randomized to the active arm of the study. The purpose of the project proposed here is to collect the data necessary to successfully design and execute the larger study. Our central hypothesis is that lack of knowledge by hem/oncologists regarding the management of HU and a lack of appropriate tools to overcome barriers to its use, as well as patient non-adherence significantly contribute to the underutilization of HU. Our goal for this R34 application is to collect preliminary data necessary to appropriately power the larger study as well as to refine and pilot the proposed multifaceted intervention for acceptability and feasibility of both the dissemination of the intervention to the providers (e.g., how to most efficiently and effectively train them) and the ability of the hem/onc providers to execute the intervention within their clinics. We are therefore pursuing the following specific aims: 1 Characterize hematology/oncology providers' patient populations and clinic practices. a. The goal of this descriptive aim is to determine the number of patients in typical hem/onc practices who are eligible for HU, which will allow us to estimate the number of providers required for the randomized clinical trial. Additionally, we will assess the level of physician interest in this type of intervention and we will assess the resources available to these physicians (e.g., the availability of support staff such as nurses) and their current adherence promotion practices in order to facilitate the successful delivery of the intervention in the randomized trial. 2. Refine and pilot a multimedia educational, web based CME intervention to improve knowledge and decrease barriers to hydroxyurea use by hematologist/oncologists. Hypothesis for large trial: A well designed intervention that addresses knowledge, negative provider attitudes toward patients and improves providers' ability to communicate with patients will increase the number of eligible patients with SCD who are prescribed HU. In preparation for the large trial we will provide preliminary evidence that our intervention is efficacious by demonstrating that the intervention: a. Improves provider knowledge of HU. b. Increases provider confidence in their ability to use/prescribe HU in SCD c. Increases provider confidence in their ability to communicate with patients reluctant to initiate HU therapy. d. Will decrease provider negative attitudes toward patients with SCD. e. [Will increase the number of patients appropriately offered HU.] 3. Develop remote training protocols and materials and pilot the feasibility of training hem/onc clinic staff to provide problem solving (PS) counseling to patients to improve HU adherence. Hypothesis for large trial: Patients randomized to problem solving sessions will have fewer hospital and ED visits for sickle crisis than those on the control arm. This improvement will be due to improved HU adherence. In preparation for the large trial we will demonstrate the feasibility of providing clinic staff with training in PS: a. Clinic staff will endorse the training experience as acceptable, feasible, and helpful, as well as an appropriate use of their time. b. Clinic staff and patients with SCD prescribed HU will endorse PS session completed during a clinic visit as acceptable, feasible, and helpful, as well as an appropriate use of clinic time. c. Coding of audio taping of counseling sessions will demonstrate that clinic staff are able to implement the PS intervention with fidelity in a real world clinic setting. d. [Pharmacy refill data will demonstrate an increase in HU refills for participating patients]